Animal Modeling Core

PROJECT SUMMARY/
The mission of the Animal Modeling Core (AMC) is to provide research groups within the YCCEH and the larger
scientific community access to the latest technologies for hematologic studies in animal models. In vivo studies
allow researchers to ask questions about the function of molecules, cell populations, and tissues within the
relevant spatial and temporal contexts. The YCCEH will continue to provide scientists training and facilitate
research in mouse models of hematologic diseases. Importantly, the AMC will continue to develop and propagate
the most innovative humanized mouse models for the study of human hematopoiesis and diseases thereof with
the goal to overcome major shortcomings of current models. The AMC consists of two cores, the Humanized
Mouse Core (HMC) and the Murine Stem Cell Transplantation Core (mSCTC). The Animal Modeling Core will
be directed by Dr Richard Flavell, Sterling Professor of Immunobiology and co-directed by Dr. Stephanie Halene,
Associate Professor and Acting Section Chief of Hematology. The HMC will offer expertise, technical assistance,
and mice for human-into-mouse xenotransplantation studies. The mSCTC will offer training and technical
assistance in the study of hematopoiesis and benign hematologic questions in mice. The Humanized Mouse
Core will facilitate human-into-mouse xenotransplantation studies into immunodeficient mice. As a unique feature
the Yale HMC will offer hematology researchers access to novel humanized immunodeficient mice optimized to
support human hematopoietic stem cells, trilineage hematopoiesis, mature myeloid cells, red cells and platelets
in circulation, and a functional human immune system. The Murine Stem Cell Transplantation Core will provide
technical expertise in the study of hematologic questions in mice. The mSCTC will offer training and expertise
for the study of hematopoiesis and hematologic diseases in mice using hematopoietic cell transplantation and
functional assays. The Animal Modeling Core will be an integral part of the YCCEH. It will provide Hematology
researchers with access to state-of-the-art technologies for in vivo studies of hematopoiesis and hematologic
diseases. It will provide teaching, expertise, and resources in an economical way. Its cores will support basic
science as well as translational studies, key to understanding and cure of hematologic diseases.